Precision Functional Mapping in Treatment-Resistant Depression

Treatment-resistant depression (TRD), defined as repeated failure to respond to treatment, is the most virulent
form of major depressive disorder (MDD), and claims a disproportionate fraction of morbidity and mortality. The
overwhelming costs of depression have motivated a decades-long search for meaningful biomarkers.
However, despite substantial effort, and the promise of functional brain imaging as a non-invasive tool for
whole-brain measurements, the identification of biomarkers of depression for ready clinical use has remained
elusive. The major impediments to progress include substantial phenotypic heterogeneity in typical MDD
cohorts and unreliable and imprecise imaging measures. During his graduate and residency years, the
principal investigator of this proposal developed novel methods for precise functional neuroimaging, known as
`precision functional mapping' (PFM), which have been previously applied to study brain organization in healthy
individuals. The present K99/R00 Pathway to Independence award proposal is designed to apply these new
methods to address these previous limitations and identify trait and state biomarkers of pathology in TRD. In
order to achieve these goals, a comprehensive career development agenda has been structured to train the PI
in the evaluation and management of this severely ill population. The PI will also learn how to implement
ecologically valid tools for precise behavioral and psychiatric assessments. These training aims will be pursued
with the guidance and mentorship of Drs. Charles Conway, Deanna Barch, Eric Lenze, Nico Dosenbach, and
Abraham Snyder, world experts in psychiatric assessment, dimensions of psychopathology, human subjects
study design, ecological momentary assessment (EMA), cognitive neuroscience, and functional neuroimaging
methods. During the training K phase, the PI will acquire a proof-of-principle dataset of extended and repeated
resting fMRI data on well-characterized TRD patients, treatment-responsive MDD patients, and healthy
controls, in order to optimize the quantitative reproducibility of single-subject functional network maps derived
from resting state functional connectivity (RSFC; Aim 1). In the R00 phase of the award, a large cohort (n=90)
of TRD, treatment-responsive MDD and healthy controls will be evaluated to identify brain imaging trait
biomarkers of treatment-resistant depression (Aim 2). To separate state from trait biomarkers, dense time
courses of imaging data, as well as EMA, will be acquired on TRD patients while they undergo
electroconvulsive therapy (ECT) treatment (Aim 3). Together, these studies are likely to reveal underlying
network features of disease and will determine whether RSFC can be reliably used as a biomarker for TRD.
The tools and approach laid out in this proposal will naturally extend to evaluations of other treatment
modalities and neuropsychiatric disorders. With the skills and expertise gained through this training and
research program, the PI will be well-positioned to pursue an independent career as a physician scientist.

Public health relevance
Treatment-resistant depression (TRD) is the most severe form of major depressive disorder (MDD), and responsible for a disproportionate portion of its morbidity. We will use a novel approach to resting state fMRI, known as precision functional mapping (PFM), to develop patient-specific biomarkers of TRD and the depressed state. Better understanding of trait and state features of depression may lead to improved diagnosis and treatment of this disabling condition.